Dissemination of a breast reconstruction decision tool through social media and online communities

PROJECT SUMMARY
Breast reconstruction after mastectomy is critical to comprehensive breast cancer treatment because it can
restore quality of life and body image, which are often impaired after mastectomy. However, many patients are
not offered reconstruction, especially those who identify as Black or Hispanic/Latina. Many patients lack
knowledge about breast reconstruction risks, and their choices about reconstruction often misalign with their
preferences. We have developed a breast reconstruction decision aid called BREASTChoice and
demonstrated its efficacy and effectiveness in two randomized controlled trials. Patients and clinicians found
BREASTChoice highly usable but requested a version they could use on a mobile device and easily share with
family and friends. Like most decision aids, BREASTChoice’s implementation has been limited to clinical
settings and had limited uptake. For dissemination of decision support to be successful, it must make decision
support available how, when, and where people want to use it. Dissemination through social media within
online communities could broaden the reach of BREASTChoice and other decision tools. Most Americans use
social media (81%) and use the internet for health information (72%). Even most older adults (60%) use the
internet. Breast cancer survivors are especially engaged in social media and online communities. Our
preliminary data suggest that breast cancer survivors would engage with BREASTChoice through social
media. Guided by the Designing for Dissemination paradigm, and in partnership with 3 cancer survivor and two
clinician organizations, we propose to adapt BREASTChoice and disseminate it through social media within
online communities. Aim 1. Adapt BREASTChoice for mobile use and online dissemination. Guided by the
ADAPT-ITT model, we will conduct iterative phases of testing in breast cancer survivors (n=45), qualitative
interviews with topical experts (n=10), and website programming changes. Adaptations will be tracked using
FRAME. Aim 2. Design and test social media messages for dissemination of BREASTChoice. Guided by
Diffusion of Innovations Theory, we will engage key community partners regarding potential adoption and
readiness for change; assess the social media dissemination context, including digital opinion leaders and
platforms; and develop and test social media messages. Aim 3. Disseminate BREASTChoice to breast cancer
survivors by leveraging social media. Using the adapted tool and tested messages, we will roll out a social
media campaign over 12 months. We will test the campaign’s exposure, reach, and engagement with
interrupted time series analysis, and BREASTChoice effectiveness (surgery choice, decision quality, decisional
conflict, satisfaction with decisions) through a longitudinal user survey. Upon completion of these aims, we will
have overcome a major scientific gap, the limited adoption of decision aids, and have developed a widely
applicable approach to disseminating decision aids outside of clinical contexts.

Public health relevance
PROJECT NARRATIVE Breast reconstruction is a critical part of comprehensive breast cancer treatment. Decisions about breast reconstruction would benefit from decision aids, which improve decision quality but are not often used. We propose to adapt a proven decision aid called BREASTChoice for use on mobile devices and to disseminate it widely by leveraging social media and online communities.